Tumor microenvironment-dependent therapy resistance

PROJECT 3 SUMMARY/ABSTRACT
The overall objective of Project 3 is to discover and exploit tumor cell extrinsic mechanisms of therapy resistance
by focusing on the contribution and targeting the immunosuppressive tumor microenvironment (TME) created
by the synergism between tumor-associated macrophages (TAM), cancer-associated fibroblasts (CAF), and
neuroblastoma (NB) cells. Our overarching hypothesis is that TAM, CAF, and NB cells synergistically
create an environment that enhances the ability of NB cells to escape targeted, cytotoxic, and immune
therapies and that TGFβ-dependent and -independent pathways play prominent roles in promoting
Adrenergic to Mesenchymal transition (AMT), producing a fibrotic ECM, and suppressing T and NK
(Natural Killer) cells cytotoxic activities. We postulate that the TME is altered in its composition and function
as tumors are treated and become increasingly rich in TAM and CAF leading to an inflammatory environment
that suppress T and NK cell cytotoxic activities and leads to therapy resistance. This hypothesis is based on
published and preliminary data demonstrating that TAM and CAF are enriched in NB tumors post-therapy, and
at relapse. We have evidence that TAM and CAF synergistically activate in NB cells NFkB and the production of
IL-6 in a TGFb-dependent mechanism and STAT3 by a TGFb and IL-6-independent mechanism. The activation
of these two pathways induces AMT and drug-resistance. We also demonstrate that therapies with B7H3
Chimeric Antigen Receptor (CAR) T-cells can target B7H3-expressing TAM and have engineered TGFb resistant
CAR T-cells. Aim 1, will determine the TME-dependent mechanisms of AMT and therapy resistance
focusing on how TGFβ-dependent and -independent pathways promote AMT, resistance to chemotherapy and
targeted therapies (with Project 1), and invasion in vitro and metastasis in vivo (with Project 2). We will
examine how the ECM stimulated by TGFβ1 contributes to AMT and to NB cell migration and motility. Last, we
will characterize the heterogeneous composition of the TME in serial human tumors with attention to spatial-
temporal arrangements and identification of distinct TAM, CAF, NB subpopulations, ECM proteins, and activated
pathways. The results of which will inform a clinically applicable multiplex immunofluorescence assay for
inclusion in NANT trials. Aim 2 will translate these discoveries in pre-clinical tumor models by targeting
TME-dependent pathways to inhibit AMT and enhance therapy response. We will test the therapeutic
efficacy of TGFβ and JAK/STAT3 inhibition in combination with chemoimmunotherapy or including CAR T-cells
using human NB lines and patient-derived xenotransplants in immunodeficient mice. We will assess the efficacy
of TGFb-resistant B7H3-CAR T- in pre-clinical TME-dependent AMT in vitro and in vivo models (with Project
4). The most effective agent(s) will then be proposed for early phase clinical trials to the NANT (Core B). Thus
Project 3 brings a unique contribution to the overall objective of this PPG through its focus on the TME and on
non-autonomous mechanisms mediating therapy resistance and immune escape.

Public health relevance
PROJECT 3 NARRATIVE Project 3 brings a unique perspective to the program project by focusing on external mechanisms (the tumor microenvironment) that – combined with intrinsic mechanisms (genetic and epigenetic alterations in tumor cells) - lead toward therapy resistance in neuroblastoma. The project has a focus on tumor-associated macrophages and cancer-associated fibroblasts that are a source of numerous inflammatory cytokines/chemokines activating TGFb-dependent and -independent pathways that promote the emergence of therapy resistant mesenchymal neuroblastoma cells. Discoveries made will lead to the preclinical testing of inhibitors of TGFb and JAK/STAT3 and to the development of TGFb resistant cellular therapies in combination with chemo-and immuno-therapy.